Higher-Order Neural Control of Food Intake

Project Summary
Improved understanding of the neurobiological systems involved in excessive caloric consumption is
critical for developing novel prevention and treatment strategies for obesity. Traditionally the field has focused
on hypothalamic and brainstem substrates that control `homeostatic' food intake that occurs in response to
energy deficits. In addition to studying these classic feeding centers, it is critical to also identify the systems
through which higher-order brain regions regulate reward-driven food seeking and consumption based on
learned, incentive, and hedonic cognitive factors. This project investigates the hippocampus (HPC) as a critical
brain substrate integrating memory processes and feeding-related signals to regulate conditioned food-
motivated behavior, including appetitive responses linked with excessive caloric intake and obesity. Our focus
is on two HPC subregions that intersect feeding behavior and memory: the ventral HPC CA1 (CA1v) and the
dorsal CA3 (CA3d). Our findings from the previous funding cycle identify a role for CA1v projections targeting
the medial prefrontal cortex (mPFC), lateral hypothalamic area (LHA), and lateral septum (LS) as pathways
functionally relevant to feeding behavior 1-3. Aim 1 experiments will advance these findings to identify the role
of three HPC projection pathways (CA1v -> mPFC, LHA, LS) in HPC-dependent associative learning tasks
that are relevant to excessive caloric intake and are based on categorically separate food-associated stimuli,
including [1] interoceptive energy status cues, [2] external contextual cues, and [3] social-based olfactory cues.
In addition to the appetitive associative memory processes described above, HPC-dependent meal-
related episodic memory (recalling who, what, when, and where surrounding a meal) powerfully influences
feeding behavior 4-8. Results from the previous funding cycle identified a neural pathway through which
gastrointestinal (GI) vagus afferent nerve (VAN) signaling, traditionally studied in the context of meal size
control, promotes HPC-dependent memory 9. Our preliminary results support the hypotheses that [1] the
stomach-derived hormone ghrelin acts via GI VAN signaling to promote meal-related episodic memory, and
[2] medial septum (MS) cholinergic signaling is a relay connecting GI VAN signaling and HPC function.
These hypotheses are investigated in Aim 2 experiments using an innovative combination of state-of-the-art
methodologies, including in vivo fiber photometry-based imaging of novel fluorescent genetically-encoded
sensors for acetylcholine (ACh) 10,11 and stomach distention-dependent electrical VAN stimulation. The extent
to which these ventral and dorsal HPC pathways converge through shared collateral projections, and/or
common downstream targets is examined in Aim 3 experiments that utilize neural pathway tracing approaches
to [1] map the collateral and 2nd-order projections of CA1v projections to mPFC, LHA, and LS, and [2] identify
downstream projections of CA3d neurons that encode GI VAN signaling. Overall results from these three
interconnected aims will identify novel neural systems that intersect memory and feeding behavior.

Public health relevance
Project Narrative Over 2/3 of adults in the USA are overweight or obese and there is currently a shortage of effective treatments to reduce the excessive food intake that leads to obesity. Novel and effective obesity prevention and treatment strategies are aided by basic science research identifying specific brain chemical systems that reduce food intake. A novel approach is taken here; we believe that more progress can be made towards obesity treatment and reducing associated health care costs if basic research were to focus on understanding neural and biological mechanisms through which learning and memory, reward, and environmental food cues interact to cause excessive feeding and obesity.